Clinical Utility of Residual Hearing in the Cochlear Implant Ear

Project Summary/Abstract
No change from original proposal.

Public health relevance
Project Narrative No change from original proposal.